Neural Bases of Cephalic Phase Endocrine Responses

PROJECT SUMMARY
Cephalic phase responses (CPRs) are autonomic and endocrine events triggered by stimulation of ‘head’
receptors, especially those of the gustatory system. These are widely considered as the first preparatory steps
required for the optimal digestion, absorption, and utilization of nutrients. Although postoral mechanisms are
clearly essential for this purpose, the significance of oral stimulation during eating for maintaining normal
metabolic function should not be underestimated. One of the most extensively studied CPRs is the early rise in
insulin that is stimulated by oral glucose. However, the insulin CPR literature is uneven, most likely because of
methodological limitations and variations in blood sampling sites. To clarify how CPRs and their underlying neural
mechanisms are organized we have developed a unique and sensitive rat preparation. It combines in a single
animal intraoral and intragastric cannulae that precisely deliver test solutions, with a hepatic portal vein (HPV)
sampling catheter. We have used this preparation in male rats to find strikingly early rises in HPV insulin and
GLP-1 levels that are significantly greater after oral compared to gastric delivery of glucose. Responses to
fructose or water showed no such oral/gastric differences. These insulin and GLP-1 increases were robust and
rapid, reaching peak levels within 3 min of orally delivering 180 mg of glucose in less than 1 min. This is the first
report of significant GLP-1 release triggered by oral stimulation with glucose. Impressively, its peak is
substantially greater than that seen after a normal meal. Considering the rapidity of both the GLP-1 CPR and its
subsequent degradation in blood, one hypothesis that we will test is whether oral glucose-driven GLP-1 release
from enteroendocrine cells acts as an incretin that mediates the insulin CPR neurally through a vago-vagal reflex.
Our design employs two experimental approaches organized in three Specific Aims to reveal the neural
mechanisms and circuits responsible for these GLP-1 and insulin CPRs. One approach uses explicitly controlled
intraoral or intragastric infusions of glucose, fructose, and control taste solutions followed by HPV measurements
of plasma GLP-1, insulin, and glucose responses. It will test whether insulin and GLP-1 CPRs can be
conditioned, and whether CPRs are recapitulated in females. The other approach will use transneuronal viral
tracing techniques combined with state-of-the-art neuroinformatics methods to map the neural pathways through
which gustatory signals control pancreatic and enteroendocrine secretions. Furthermore, both approaches use
functional nerve transections to define the organization of the neural pathways driving GLP-1 and insulin CPRs.
The project is a scientific alliance of highly experienced investigators who have complementary expertise. Its
outcomes will provide new insights into the neural control of insulin and GLP-1 secretion. It will also define
mechanisms that could be therapeutically targeted to facilitate treatment strategies for patients requiring enteral
or parenteral nutrition, as well as promoting healthier eating and nutrient assimilation in the general population.

Public health relevance
PROJECT NARRATIVE Oral contact with food and fluid can directly impact blood levels of insulin and glucagon-like peptide-1, two essential hormones that control blood glucose, feeding, and body weight. It is therefore important to understand how the oral cavity, brain, and gut work together to modulate the release of these hormones. Such knowledge should advance the development of therapeutic interventions for type-2 diabetes, facilitate treatment strategies for patients who cannot eat and drink orally, and promote healthier eating and nutrition in the general population.